Community Care Utilization among Post-9/11 Veterans with Traumatic Brain Injury

Background: Estimates suggest that 20% or more of Post-9/11 Veterans have experienced at least one
military-related traumatic brain injury (TBI); the majority are categorized as mild (mTBI). TBI of all levels of
severity, including mTBI, can lead to chronic physical, cognitive, and emotional symptoms that, for many,
interfere with daily functioning. It is also associated with comorbid diagnoses such as posttraumatic stress
disorder, depression, pain, dementia, and suicidal ideation. As such, early detection and coordinated treatment
are critical for preventing chronic dysfunction, disability, and early mortality among Veterans with TBI history.
The VA Polytrauma/TBI System of Care (PSC), through a regional, integrated structure, serves this function by
overseeing and providing screening, evaluation, education, and evidence-based treatment for those in need of
TBI-related care. The PSC will care for this substantial patient population for decades to come.
Since the 2014 passage of the Veterans Choice Act and, more recently, the VA MISSION Act, the VA has
been outsourcing larger amounts of healthcare to non-VA providers (“Community Care”). VA Community Care
may improve Veterans’ access to care; however, dual use of healthcare systems and providers can lead to
poor outcomes due to fragmentation of care. Preliminary work has suggested that higher proportions of
Veterans with TBI diagnoses, relative to those without TBI, are receiving VA Community Care services, and
that this may be leading to the receipt of therapies that are not recommended for patients with TBI.
Significance/Impact: This study will inform the development and implementation of strategies to enhance the
care received by Veterans with TBI who use VA Community Care services. This work will identify gaps in the
provision of evidence-based TBI care in a timely manner, as VA Community Care services continue to expand
under the new MISSION Act. Our results will help ensure that Veterans with TBI receive care that is
coordinated, interdisciplinary, and evidence-based, and that promotes their optimal health and functioning.
Innovation: This project will develop new knowledge about Community Care utilization and outcomes among
Veterans receiving care for TBI, a high-priority, clinically-complex patient population. It will be the first, to our
knowledge, to measure patient-reported health and functional outcomes among Veterans who receive
Community Care. Additionally, we will link to multiple VA and Department of Defense (DoD) databases to
objectively account for differences in characteristics between those who do and do not use Community Care.
Specific Aims: Our aims are to: (1) Describe utilization of VA Community Care (rates and types of; reliance
on) among Post-9/11 Veterans with TBI; (2) Estimate associations between Veterans’ reliance on Community
Care and their health and functional outcomes; and (3) Understand Veterans’ need for, perceptions of, and
experiences with VA Community Care.
Methodology: This 4-year, mixed-methods project will link data identifying Post-9/11 Veterans with TBI to
administrative data identifying VA healthcare use including Community Care. For Aim 1, we will examine
patterns of Community Care use (rates and types of; reliance on) over time and by Veterans’
sociodemographics, military history, TBI severity, medical complexity, and PSC utilization history. For Aim 2,
we will survey a stratified, random sample of 1,800 Veterans with TBI to estimate associations between their
reliance on Community Care and their health and functional outcomes, while accounting for potential
confounders and sources of bias. For Aim 3, we will interview 100 Veterans to examine factors related to their
access to, satisfaction with, trust of, and actual and perceived quality of Community Care.
Implementation/Next Steps: This work may identify subgroups of Veterans whose healthcare needs are not
being met and who are at risk of poor outcomes. Results will inform strategies to ensure continued delivery of
coordinated, high-quality care across the entire spectrum in which Veterans with TBI are receiving VA care.

Public health relevance
An estimated 20% or more of Post-9/11 Veterans have had at least one military-related traumatic brain injury (TBI). Veterans with TBI are often co-diagnosed with neurological, mental health, and pain disorders that interfere with daily functioning. The VA’s Polytrauma/TBI System of Care (PSC) is an interdisciplinary program designed to meet the needs of Veterans with TBI and maximize their health and functioning using evidence-based practices. However, since the passage of the Veterans Choice and MISSION Acts, many Veterans with TBI are also receiving services from the VA’s network of Community Care providers. Dual use of services can lead to fragmented care, which may be particularly detrimental to Veterans with complex healthcare needs. This study will describe the use of Community Care (e.g., rates and types of; reliance on) among Post-9/11 Veterans with TBI; estimate associations between their Community Care reliance and health and functioning; and examine their experiences and satisfaction with Community Care.